Core A: Administrative Core

PROJECT SUMMARY (See instructions): Administrative Core, under the direction of BU SRP Program Director, Dr. Ozonoff, provides infrastructure for fiscal and administrative support for the projects and cores; coordinates research activities and enhances integration of research objectives; and promotes transfer of SRP products to professional, public and private sector and community stakeholders. It a means to communicate needs to and from the SRP and its stakeholders. Formal and informal lines of communication are kept short. The Program Director makes final decisions in close collaboration with an Internal Executive Committee (lEC) consisting of a Deputy Director, the Director of Boston University Medical Center's Director, Translational Bioinformatics Program, Clinical and Translational Science Institute, the Director of the Community Engagement and Research Translation Cores and two Project scientists, one with expertise in field studies and the other bridging the bench science offish and mammalian molecular ecology and toxicology. The lEC meets weekly and assists in operational matters, while a larger PI Committee of project leaders convenes on an approximately monthly basis to discuss research, policy issues and Core usage. An administrator manages fiscal details, communicates with counterparts at NIEHS, and answers directly to the Program Director. An administrative assistant staffs the cores and is webmaster for the Program. The Administrative Core also manages communication and visits of a five member External Advisory Committee.

Public health relevance
RELEVANCE (See instructions): The Administrative Core provides financial management, auditing and monitoring for allocation of resources and fiscal accountability; supports coordination, communication and cooperation between projects; ensures that the Bioinfonnatics and Computation Modeling Research Support Core meets project needs efficiently and effectively; makes sure the Community Engagement, Research Translation and Training Cores function as intended; and provides mechanisms for efficient communication with NIEHS and EPA.